SPARC Engagement Plan with the Common Fund Data Ecosystem

Modified Project Summary/Abstract Section
The SPARC Knowledge Management and Curation Core (K-Core) is engaged with the Common Fund Data Ecosystem (CFDE) through a number of activities: 1) Continue to actively participate in and engage with CFDE; 2) Continue to participate in working groups and carry out Working Groups’ recommendations; 3) Contribute SPARC (i) resource metadata to C2M2 [2], (ii) develop and maintain necessary services to support data within the CFDE Portal (e.g. DRS services), and (iii) ensure users are able to access SPARC data in the cloud; and 4) participate in other CFDE projects as needed. Metadata and asset ingestion into the data resource portal will include the production of C2M2 data submission manifests and the upload of these manifests to the CFDE Workbench including specification of ontology mappings. This will also entail maintenance of the SPARC data submission export pipeline to support updates in SPARC metadata and any updates to the CFDE submission process. As the SPARC DRC is now also supporting data publication through other initiatives (e.g. NIH HEAL) we will also work with CFDE to determine best ways to annotate these data assets that have begun to be published. Additional asset ingestion into the data resource portal will continue to include knowledge graph assertions from the SPARC Connectivity knowledge graph (SCKAN). In addition, we will pilot the contribution of assertions from the Functional Connectivity Map – which is focused on biological compartments, their connectivity, their protein and small molecule constituents, as well as related biophysical models that study related processes (e.g., fluid flow, drug transport). This FC Map currently contains knowledge for ~300 drugs and~900 related gene products, and explicitly represents knowledge about relevant tissues, cells, fluids, protein and small molecules. We will generate RDF models of FC Map metadata, leveraging semantic standards adopted by the Ontology Working Group for integration with CFDE.

Public health relevance
Modified Public Health Relevance Section The proposed activities will enhance the accessibility, interoperability, and reuse of SPARC data within the NIH Common Fund Data Ecosystem by aligning metadata, contributing to knowledge graphs, and maintaining robust data pipelines. This work ultimately supports public health by enabling researchers to more efficiently use complex biological data to advance treatments for conditions affecting multiple organ systems.